Flow Cytometry

Project Summary/Abstract - FLOW CYTOMETRY SHARED RESOURCE
The UNMCCC Flow Cytometry Shared Resource (Flow Cytometry) supports basic and translational cancer
research by providing cost-effective, full service flow cytometry services and high-speed sterile sorting of cells,
including the analysis of patient samples, to UNMCCC members and non-member users. Faculty Director
Jennifer Gillette, Ph.D. (CMO) supervises the Resource, which is operated by a full-time core technical director,
Wade Johnson, Ph.D. The UNMCCC Research Administration manages the Resource, which provides several
types of flow cytometry services including instrumentation for complex multi-panel analysis as well as single cell
sorting into microplate wells for cloning, PCR, and RNA-sequencing analysis. Reservations, billing and usage
are tracked through a centralized on-line system. Additionally, the Resource manages the flow cytometry data
analysis contract for the institution, which individual labs can buy into at a reduced price. The Resource Director
and staff work closely with UNMCCC research programs to develop new methodologies that promote innovative
basic and translational research goals. Moreover, the Resource actively promotes and disseminates information
about new flow cytometry and data analysis techniques by maintaining an up-to-date web page and by giving
presentations at UNMCCC meetings and retreats. Finally, the Resource Director and staff actively engage in the
education mission of the UNMCCC through training and participation in several graduate level courses. During
the previous 5-year project period, 58 UNMCCC members from 3 UNMCCC Research Programs were
responsible for 75% of total Resource usage. Additionally, the Resource supported 146 publications and 128
peer-reviewed grants.